Role of the inflammatory dietary pattern in gut and colon tissue microbiomes and impact on survival outcomes among colorectal cancer patients

Colorectal cancer (CRC) is the 3rd most commonly diagnosed cancer and 3rd leading cause of cancer-related
deaths in the United States. Poor dietary quality and the gut microbiome are related modifiable factors implicated
in the burden of this disease. However, the mechanisms through which they interact to impact CRC development
and progression are poorly understood. Our team previously developed the novel Empirical Dietary Inflammatory
Pattern (EDIP) score based on plasma inflammatory markers. A higher EDIP score is linked with higher levels
of inflammation and a higher risk of developing CRC and dying from the disease. Though diet has been shown
to modulate the gut microbiome, the dietary effects that trigger inflammation and dysbiosis in CRC are largely
unknown. We have shown that a pro-inflammatory dietary pattern (higher EDIP) is associated with a higher risk
of developing CRC in which the tumor is depleted in tumor-infiltrating lymphocytes (TILs) and that among CRC
survivors, higher post-diagnosis EDIP also predisposed patients to die from tumors with depleted TILs, but not
tumors with high levels of TILs. We further demonstrated that higher EDIP was associated with greater risk of
colorectal tumors enriched with a bacterium called Fusobacterium nucleatum but not with tumors negative for F.
nucleatum. These findings shed light on a potential mechanism for how diet-related inflammation may influence
CRC tumor development and progression. However, our studies were limited to a single bacterium in colon
tissue, and we now have the ability and expertise to use more robust methods to identify diverse microbes
(bacteria, fungi, viruses, etc) and a wider range of host immune cells within tumors. Based on our preliminary
data, we will test the overarching hypothesis that a pro-inflammatory dietary pattern reduces concentrations of
important cancer-fighting immune cells in the colon and alters the overall balance of microbes in colon tissue,
thereby increasing the risk of developing aggressive CRC that will lead to death. We will leverage data among
291 men and women in the Colocare cohort with diet and stool samples to identify gut microbes associated with
EDIP and assess their impact on survival among CRC patients. In addition, we will utilize RNAseq data from the
Oncology Information Exchange Network (ORIEN) among 2500 CRC patients to identify microbes and immune
cell in CRC tumor tissue linked to EDIP and determine their impact on tumor clinical characteristics (e.g., CRC
stage), host factors (e.g., sex, body mass index), and survival outcomes (recurrence, all-cause mortality, CRC
mortality). At the completion of our study, we expect to have a) identified the microbes associated with the
inflammatory dietary pattern in the gut and within CRC tumor tissue and b) determined how these EDIP-related
microbes are linked to survival outcomes among CRC patients for the first time. These results will inform the
design of larger studies of dietary strategies for mitigating dysbiosis in the gut and tumor tissue associated with
proinflammatory (high-EDIP) dietary patterns and CRC progression. These novel strategies may also serve as
adjunct therapies to improve anti-cancer treatment responses while reducing side effects.

Public health relevance
Project Narrative Our contribution in this project is expected to be the identification of gut and tumor tissue microbes and immune cells linked to the Empirical Dietary Inflammatory Pattern (EDIP) that drives malignant progression in colon tissue and underlies poor survival among colorectal cancer patients. Our study includes two major aspects of innovation: 1) Integrating a pipeline of novel sensitive bioinformatics tools (elasticnet and exotic) i) to detect parsimonious, yet highly informative microbial profiles in the gut (stool samples); and ii) to isolate a wide range of microbes typically in low abundance (compared to human immune cells) in the tumor microenvironment; while 2) demonstrating how a specific diet pattern (EDIP) influences gut and tumor tissue microbiota, their interactions with immune cells and the consequent clinical outcomes of these interactions for CRC progression and death. This contribution is relevant to public health because it is expected to provide a solid foundation upon which to design precision medicine-based dietary pattern strategies for mitigating inflammatory dietary pattern-related (high-EDIP) gut and tumor tissue microbial dysbiosis and improving the survival of CRC patients.